Building Cultures of Recovery in Tribal Communities - Capacity Building Core

PROJECT SUMMARY The proposed project will build capacity by training community members within seven tribal nations to use an innovative, culturally appropriate community-­based mental health first response system. While completing our NARCH VIII program activities, we developed academic/community partnerships within these tribal communities, and we learned about each community’s existing resources and infrastructure. We will leverage these partnerships and apply this knowledge to complete the NARCH X Capacity Building activities. More specifically, we will seed the seven tribes with individuals who are equipped to help experiencing mental health crises, particularly youth in recovery from substance use disorders. Early Capacity Building Core activities will include assisting with the development of the core First Face modules and training Healing Lodge research staff to conduct research activities. Later, working alongside tribal Working Groups, we will expand First Face by developing additional modules, including tribe-­ specific modules;? revise the First Face curriculum in response to feedback from trained community members;? continue to build research capacity;? and develop enduring and formalized First Face training materials. During the final year of the project, we will train hundreds of tribal community members in the First Face program and lay the foundation for a self-­sustaining First Face training center at the Healing Lodge, complete with a First Face “Train-­the-­Trainers” program that the Healing Lodge can offer to interested tribes and individuals. In sum, we will build capacity for tribal communities to learn and apply the First Face program, thus sparking a mental health culture change across these communities.